Understanding Interorgan Communication Through Heterochronic Organ Transplantation

SUMMARY
Dynamics of interorgan communication and biological age change as a function of chronological age but these
dynamics and the underlying mechanisms are not well understood. Organ transplantation offers a clinically most
relevant model with donor/recipient age-discrepant combinations representing a clinical routine to meet the ever-
increasing organ demands. Our published studies and preliminary data show that an elevated donor age drives
the immunogenicity of organs leading to augmented alloimmune responses with higher acute rejection rates.
This, in turn, is blunted with the increase of recipient age, demonstrating both clinical relevance and inter-
organ/recipient communication. These clinically relevant scenarios raise the possibility of potential rejuvenation
and/or accelerated aging when performing heterochronic organ transplants. We have shown that the recipient
environment can affect the biological age of transplanted organs. Specifically, when transplanting old organs in
young recipients, we observed the reduction of donor organ biological age. At the same time, old organs
transplanted into young recipient mice promoted aging, which not only led to an accumulation of senescent cells
in peripheral organs, but also to a decline of physical and cognitive functions. Our project brings together a
synergistically positioned group of aging and transplantation researchers and clinicians. Vadim Gladyshev (MPI)
is an expert on aging biomarkers and the biology of aging. Stefan Tullius (MPI) is a clinician/scientist who provides
the clinical perspective. The latest generation of aging biomarkers based on omics approaches, combined with
state-of-the-art model systems place us in an unprecedented position to study inter-organ dynamics of aging.
Our hypothesis is that that young and old cells transferred with an organ transplant may exert rejuvenating and
aging effects extrinsically. This hypothesis will be tested in our established transplant models of clinical relevance
and confirmed using a unique clinical database. We also hypothesize that transplanted organs will acquire the
biological age approaching that of recipients. This includes the situation wherein old donor organs will be
rejuvenated in young recipients, potentially increasing the use of discarded organs. This approach is significant
and innovative in (i) delineating novel mechanisms of interorgan communication in a clinically relevant
heterochronic transplantation model with perturbation of specific tissues, (ii) the use of state-of-the-art tools of
aging science to characterize changes in biological age dynamics, (iii) the use of detailed mechanistic
approaches to pinpoint changes in interorgan communication upon biological age perturbation; (iv) synergistic
efforts of research groups combining deep complementary expertise in preclinical and clinical studies of aging
biology and transplant medicine; and (v) real-world implications of the proposed work. These studies position us
to substantially advance understanding of interorgan communication with regard to biological age, with the
potential to delineate novel pathways in support of organ rejuvenation and the prevention of transferring age-
accelerating effects with organ transplantation.

Public health relevance
NARRATIVE Heterochronic or age disparate organ transplantation is a standard clinical practice with the potential of transferring rejuvenation (when transplanting young organs) or accelerated aging (when transplanting old organs), as well as with the potential for age reduction of donor organs in younger recipients. We have accumulated data on changes in biological age and compromised physical and cognitive capacities in experimental models supporting the concepts of organ rejuvenation and accelerated aging. A unique set of tools in transplantation models of translational relevance will delineate mechanisms of inter-organ communication.